ROLE OF GLIAL CIRCADIAN CLOCK DYSFUNCTION IN THE PATHOGENESIS OF ALZHEIMER'S DISEASE

PROJECT SUMMARY/ABSTRACT
Role of glial circadian clock dysfunction in the pathogenesis of Alzheimer’s Disease
Chronic disruptions of the circadian system, manifesting as sleep disturbances, day-night confusion, and
“sundowning”, are well-described and debilitating symptoms of Alzheimer’s Disease (AD). While circadian
disruption has long been considered a consequence of the degenerative process in AD, accumulating human
and mouse data suggest that circadian rhythm abnormalities may begin before overt cognitive symptoms, and
could play an important contributory role in AD pathogenesis. Circadian rhythms are generated in cells by
specific clock genes, which are expressed in neurons and glia throughout the brain and control 24-hour
oscillations in transcription. These cellular clocks are synchronized to the external environment by the central
clock in the suprachiasmatic nucleus in the brain. Cellular circadian clocks are particularly robust in glial cells,
regulating cellular activation and inflammatory responses in both astrocytes and microglia. We have found that
the circadian clock protein BMAL1 regulates astrocyte activation, neuroinflammation, and amyloid plaque
deposition in mice. We have also found that amyloid plaques cause large-scale alterations in circadian
transcriptional rhythms in astrocytes. Thus, we will address the bidirectional relationship between circadian
clock disruption and AD-related pathology in mouse models of AD, focusing on how the central and cellular
clocks regulate astrocyte responses to protein aggregation. Using novel methods to interrogate cell type-
specific transcription in vivo, we will compare the effects of central vs. cellular clock disruption on circadian
function in astrocytes, both in healthy brain and in a model of AD. We then evaluate the effects of central and
cellular clock disruption on pathology caused by Aβ and tau, and determine specific clock-regulated pathways
in astrocytes that control protein degradation and inflammation. By understanding the bidirectional relationship
between circadian rhythms and astrocyte function, we hope to identify novel therapeutic targets to prevent
protein aggregation and inflammation in Alzheimer’s Disease.

Public health relevance
PROJECT NARRATIVE Patients with Alzheimer's Disease have disturbances of circadian rhythms, the 24-hour cycles that control bodily processes such as sleep and hormone secretion. We will investigate how Alzheimer's Disease changes the circadian rhythms in different cell types in the brain. Conversely, we will determine how disruption of the circadian system in different cells of the brain causes inflammation and toxic protein accumulation in mouse models of Alzheimer's Disease.